Alcohol and gut-brain axis and the role of butyrate on neuroinflammation and pain sensitivity

ABSTRACT
Chronic pain lasts for months or years which negatively impacts quality of life. Alcohol, an effective analgesic,
is commonly used to self-medicate for pain, and strongest analgesia occurs for alcohol levels exceeding World
Health Organization guidelines for low-risk drinking, which could explain alcohol misuse in those with persistent
pain. The gut microbiota regulates many neurological disorders, including chronic pain. Both alcohol use
disorder (AUD) and many pain disorders are associated with a disruption in microbiome composition and
function (gut dysbiosis), neuroinflammation, neuronal damage, and behavioral alterations. Gut microbial-
derived short-chain fatty acids (SCFA: e.g., butyrate) are important in regulating the gut barrier, modulating
immune and inflammatory responses, and gene expression due to their histone deacetylase (HDAC) inhibitor
activity and/or interactions with G-protein coupled receptors (GPCR). Epigenetic modulation of gene
expression has emerged as a key regulator of the alcohol withdrawal state, and HDAC inhibitors are proposed
as therapeutic targets for the treatment of emotional dysregulations associated with alcohol withdrawal and
chronic pain. Butyrate crosses the blood brain barrier and is detected in the cerebrospinal fluid. Butyrate
delivery improved cognitive impairments and neuronal plasticity induced by drugs of abuse via modifying
HDAC activity. Butyrate is also anti-inflammatory as a ligand for GPR43, which is expressed on many cell
types including intestinal epithelial cells and peripheral blood mononuclear cells. In unpublished studies, we
have found chronic ethanol exposure and withdrawal in mice caused gut dysbiosis, depleted butyrate-
producing bacteria and luminal butyrate, and induced plasma endotoxin. Concurrently, there was evidence of
microglial activation, increased levels of proinflammatory cytokines, and heightened HDAC activity and
reduced GPR43 expression in the brain, leading to increased pain sensitivity during ethanol withdrawal. Our
prior studies show butyrate supplementation normalized intestinal epithelial barrier, systemic endotoxin levels
and liver injury in mice exposed to ethanol. Our central hypothesis is that two butyrate targets, HDAC and
GPR43 activity, are altered in the brain during chronic ethanol exposure due to depleted gut luminal butyrate
and this contributes to neuroinflammation and alters pain sensitivity. We will test 3 specific aims: 1) Determine
whether butyrate-targeted oral supplementation inhibits HDAC activity, neuroinflammation, and pain sensitivity
in mice exposed to chronic ethanol exposure and withdrawal; 2) Determine the role of butyrate and GPR43 on
astrocyte reactivity, neuroinflammation and pain sensitivity during chronic ethanol exposure and withdrawal;
and 3) Define the link between gut microbiome, butyrate levels, peripheral immune and inflammatory profile,
and pain sensitivity in chronic pain patients consuming alcohol. Completion of these studies will increase our
knowledge to uncover therapeutic targets for future drug discovery and development for alcohol use and
chronic pain syndromes.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder (AUD) and chronic pain conditions are leading causes of morbidity worldwide; and both conditions alter gut microbiome composition and function (gut dysbiosis) which can induce intestinal permeability, increase circulating endotoxins and cause inflammatory responses that drive organ injury. We recently showed the gut fermentation byproduct butyrate normalizes ethanol-induced gut permeability and associated liver inflammation and injury, but how butyrate affects the gut-brain axis in the context of chronic alcohol use and pain is uncertain. Here we will determine mechanisms for the protective effects of the gut microbial metabolite butyrate in neuroinflammation and pain sensitivity, with the long-term goal of this project to identify therapeutic targets for future drug discovery and development for alcohol use and chronic pain syndromes.